MOLECULAR GENETIC ANALYSIS OF TREPONEMA DENTICOLA

Oral spirochetes are strongly associated with most forms of periodontal diseases, and are capable of penetrating these tissues of the human gingiva. The unique locomotory characteristics imparted by the spirochetal periplasic flagella may contribute to virulence, but the molecular control of sirochetal motility and chemotaxis is not well understood. We have isolated a gene cluster from the oral spirochete, Treponema denticola ATCC35405, which encode homologs of key flagellar motor and switch proteins. Analysis of deduced protein sequence revealed an open reading frame with 58% identity with fliG protein of Bacillus subtilis. Further, analysis of an ORF 5' to the putative FliG gene revealed highly significant homologies with the structural genes for the MS ring protein, FliF, in Salmonella and Bacillus. Tightly linked to these flagellar genes, is an open read frame, ORF-T resembling protease/chaperonin genes such as the leukotoxin regulatory locus, lapA, of Pasteuralla hemolytica and the clpX protease of E. coli. This linkage raises the possibility of involvement of this protein in regulation of flagellar assembly or export of flagellar components. Further analysis of the genetic and transcriptional organization of the genes encoding the flagellar components is under way to define promotor regions, additional gene products, and the significance of the linkage with the ORF-T. Further characterization will provide valuable information about the molecular architecture of spirochetal flagella, the genetic control of flagellar biosynthesis, and the regulation of motility and chemotaxis in treponemes. Interestingly, these genes were initially identified based on the reactivity of their products with sera from adult periodontitis patients, and we are also pursuing identification of the immunoreactive species. KEY WORDS: Clones, periodontal disease, recombinant antigens, T. denticola,